Development of CD4 TCR-engineered T cell immunotherapy in triple-negative breast cancer

Abstract
Breast cancer is a leading cause of cancer-related deaths of women in the United States and worldwide.
Immunotherapy is a promising approach, but has not proven successful yet in metastatic breast cancer,
particularly in triple-negative breast cancer (TNBC). TNBC is the most aggressive subtype among all breast cancer
subtypes, with little treatment options available. First-line treatment with pembrolizumab–chemotherapy results in
better overall survival than chemotherapy alone among patients with advanced TNBC. Sacituzumab Govitecan is
offered as an option for the second line of treatment. Despite these significant progresses, most patients eventually
collapse and die without further treatment option. Thus, TNBC remains an unmet medical need for urgent
development of novel therapeutics. The rationale for this application is that clinical responses to immune
checkpoint therapy rely on the presence of tumor-infiltrating and antigen-specific T cells. Thus, development of
tumor-specific TCR-T cell immunotherapy is key to the success of immunotherapy in breast cancer. Immunova
Therapeutics is a startup company with the mission to further develop TCR-T cell immunotherapy for the treatment
of solid cancers, including TNBC. Due to the nature of tumor heterogeneity, antigen loss or negative tumor variants
represents a key mechanism to develop resistance to immunotherapy. This IMT-422 product is an HLA-DR13-
restricted KK-LC-1-specific TCR-engineered CD4+ T cells, and has been demonstrated to completely inhibit or
even eliminate TNBC in a mouse model. Our finding is also supported by recent studies showing that CD4+ T cells
could eliminate antigen-positive and -negative tumor cells. To further improve the therapeutic potential, we
engineered TCR with three key technologies to increase the pools of stem-like memory T cells and resistance to
T cell exhaustion and immune suppression. We named the final IMT-422 product as CD4 TCR-STEM T cells,
which could completely reject breast cancer growth in a mouse model. Based on these solid data, we propose to
generate GMP grade Master Cell Bank (MCB) and viral particles of TCR-STEM required for Chemistry,
Manufacturing and Controls (CMC) (Aim 1); and determine the pharmacokinetics, biodistribution and
pharmacological toxicity of the IMT-422 (CD4 TCR-STEM T cells) product (Aim 2). Upon completion of the
proposed studies, we are well positioned to initiate and file an investigator-initiated new drug (IND) application for
a future phase I clinical trial, thus accelerating the development of new breast cancer immunotherapy.

Public health relevance
PROJECT NARRATIVE Breast cancer is a leading cause of cancer-related deaths of women in the United States and worldwide. This SBIR-II application is to develop a novel T cell receptor-engineered CD4 T cell immunotherapy by targeting cancer-testis antigen KK-LC-1. To further improve the therapeutic potential, three key technologies have been incorporated into CD4 TCR-STEM T cell product by promoting stem-like memory T cells and resisting to immune suppression. The goal of this project is to develop GMP grade master cell bank and viral supernatants and determine the biodistribution and toxicity of CD4 TCR-STEM T cell product (IMT-422). The positive outcome of our proposed investigational new drug (IND)-enabling studies will accelerate the development of therapeutic CD4 TCR-STEM T cell immunotherapy, and shift the paradigm by paving the way for the development of novel immunotherapies to eradicate breast cancer (particularly triple-negative breast cancer).